The interaction between analgesic medication and exercise-induced musclehypertrophy in patients with low back pain

Low back pain (LBP) is a complex condition that affects 65-85% of the population, and is the leading
musculoskeletal condition contributing to disability in the United States. Seventy-five percent of
individuals undergoing treatment for this condition experience suboptimal or poor outcomes in the form of
disability and deficits in functional capacity, including strength and endurance of the lumbar musculature.
The most common initial treatments for individuals with chronic LBP are exercise-based rehabilitation,
and pharmacological management in the form of analgesic medications. Although these two
conservative treatment modalities are often concurrently prescribed, the influence of analgesic
medications on the capacity of muscle to adapt in response to exercise is unknown. Importantly, in
healthy individuals, some of these medications have been shown to inhibit muscle protein synthesis,
metabolism, and stem cell function. The influence of medications may explain the variability in muscle-
specific and clinical outcomes associated with exercise-based rehabilitation in this population. To
address these current gaps in the literature, we propose to define medication usage patterns and clinical
outcomes across individuals with chronic low back pain who are participating an exercise-based
rehabilitation program. Specific Aim 1 will investigate the influence of symptom interference,
psychosocial factors, and diagnosis on analgesic medication use relative to exercise in individuals with
LBP. Specific Aim 2 will evaluate the influence of medication type, dose, and timing on exercise
performance. Finally, Specific Aim 3 will determine if medication type, dose, and timing influences the
magnitude of muscle hypertrophy and clinical outcomes after completion of a 12-week resistance
exercise program. Determining the impact of common analgesic medications on muscle hypertrophy,
exercise performance, and clinical outcomes is an important step in optimizing conservative
management in individuals with low back pain. This information will also be applicable to a variety of
musculoskeletal conditions for which similar treatment strategies are employed. This contribution is
significant because it is the first step in a precision medicine approach aimed at establishing appropriate
and targeted exercise and analgesic medication prescriptions for reversing muscle impairments that
obstruct patient recovery. This proposal is innovative because it aims to fill a large gap in knowledge
regarding the influence of analgesic medication on muscle adaptation in individuals with pain and
pathological muscle.

Public health relevance
Low back pain (LBP) is a condition that affects a majority of the US population and has a high incidence of recurrent and persistent symptoms. Exercise-based rehabilitation and pharmacological management in the form of analgesic medications are often the first line of treatment in individuals with chronic LBP, however the interaction between these two treatment modalities is unknown. Here, we will compare medication usage patterns, exercise performance, and clinical outcomes in patients undergoing exercise-based rehabilitation that are taking different analgesic medications in an attempt to identify the interaction between medication and responsiveness of muscle to exercise in individuals with chronic LBP.